Arbovirus Transmission Dynamics Across a Metapopulation Undergoing Environmental and Social Change

Abstract
Aedes-borne viral diseases are associated with explosive urban epidemics, but rural transmission is undergoing
expansion and its role in virus maintenance is poorly understood. Transmission dynamics at a regional level
requires us to go beyond conceptualizing dengue as urban or rural, terms that are administrative and political
rather than etiologic. Borrowing from metapopulation theory, the transmission dynamics of dengue are better
analyzed using spatial terms like patches that describe environmental, social, and biological dynamic processes
at multiple scales. Our overall hypothesis is that dengue and Zika virus (DENV, ZIKV) transmission dynamics
occur at multiple geographic scales, driven by connections among human movement patterns, social networks,
and mosquito densities at fine scales (within locations) and by regional, national, and international transportation
networks at larger scales. Given its relevance we will study DENV as the predominant pathogen; given the
immune imprint that ZIKV leaves, we will include it and monitor any other Aedes-borne viruses that may circulate
or emerge in any given year. The relative contribution of intra- and inter-location movements depends on key
geolocatable characteristics that we categorize as landscapes (e.g., weather, structural and surface features),
bioscapes (e.g., mosquito behavior and human immunity), and socioscapes (e.g., movement, social networks).
We propose to study DENV transmission dynamics in northwestern coastal Ecuador where communities reside
in a heterogeneous array of changing environments and where we have documented very recent introduction
and establishment of DENV as well as high Zika seroprevalence. We will address our overarching hypotheses
through parallel longitudinal cohorts of human (Aim 1) and vector (Aim 2) populations in regionally representative
communities to characterize the transmission dynamics at multiple geographic scales (Aim 3). Aim 1 focuses on
the question: What is the force of DENV infection and the rate of virus introduction across the diverse landscape
within 6 communities (across a remoteness gradient)? Aim 2 focuses on the question: How do key entomological
parameters (vector bioscape) drive local DENV transmission within distinct landscapes of unique interconnected
communities in Northwestern Ecuador? And Aim 3 focuses on the question: Can a collection of smaller
communities, connected through a transportation and social network, function (socioscape) like a larger
population center to sustain and seed transmission? This R01 will provide fundamental insights into how a
changing environment influences heterogeneous transmission patterns as well as epidemiological and
immunological interactions between DENV and ZIKV. These insights can provide information crucial to
developing optimal control strategies for Aedes-borne diseases.

Public health relevance
Narrative Dengue and other Aedes borne viruses have traditionally been considered an urban disease, however, there has been increasing documentation of dengue transmission in rural communities. We propose to study dengue transmission dynamics in northwestern coastal Ecuador where there exists an array of urban and rural environments including the capital city of Esmeraldas, smaller communities along a road, and more remote communities that only have river access.